INFLUENCE OF T CELL ACTIVATION ON THE REGULATION OF HIV REPLICATION

Determine the relative importance of different T cell activation components in the induction of HIV replication, and the influence of viral early gene product, Nef, on these required activation events.